FAACS: Feasibility/Acceptability of Attentional-Control Training in Survivors

PROJECT SUMMARY/ABSTRACT
Survival rates are increasing for common pediatric cancers, including acute lymphoblastic leukemia (ALL) and
brain tumors; yet the life-saving treatments for these cancers place survivors at heightened risk for sustained
cognitive effects. Longitudinal research has shown that the cognitive burden of ALL and pediatric brain tumors
may consist of impairments in attention, working memory, and executive functioning, which results in long-term
disruption to daily living, socialization, academic achievement, and quality of life. Few non-pharmacological
interventions exist to ameliorate these cognitive late effects, but the results have been promising. The most
widely studied intervention, Cogmed, is an electronic cognitive training program that has been shown to
improve working memory, but has not resulted in broad functional improvement. Thus, it may be that a multi-
domain approach is needed to generalize treatment effects to real-world functioning. Endeavor, an FDA-
approved electronic attentional-control training program, may be one intervention to help compensate for the
executive functioning difficulties experienced by survivors. Although the program has been efficacious for youth
with Attention-Deficit/Hyperactivity Disorder (ADHD), it has not yet been tested among survivors of childhood
ALL or brain tumor. Therefore, a pilot randomized controlled trial is proposed to assess the feasibility,
acceptability, and preliminary efficacy of Endeavor. Survivors of ALL or brain tumor who are between the ages
of 8 and 16 and have been off-therapy for at least one year will be included. The goal is to enroll 40
participants across three pediatric oncology centers. Patients will participate in either the Endeavor
intervention, which includes 25-30 minute sessions per day, 5 days per week, for one month, or an active
control condition. Patients will undergo neurocognitive testing pre- and post-intervention, and parents will
complete questionnaires regarding their child’s functioning. It is hypothesized that this attentional-control
training program will be both acceptable and feasible, with sufficient enrollment, positive satisfaction ratings,
and at least 80% treatment compliance. It is also anticipated that participants will show increases in
performance-based and parent-rated attention, as compared to those in the active control condition. These
results will be essential to our conceptualization of the utility of Endeavor and will inform a larger randomized
trial of the efficacy of this training program. Taken together, this pilot study will have important implications for
the development of cognitive remediation options for survivors of childhood ALL and brain tumor.

Public health relevance
Project Narrative: Survivors of pediatric acute lymphoblastic leukemia (ALL) and brain tumors (BT) often develop problems with learning, attention, and other thinking skills after finishing treatment. These problems can make it more difficult for them to learn at school, get along with people, and be successful in daily activities. We propose to test whether a program that has been shown to help improve attention skills in other groups of children, EndeavorRx, is feasible and helpful to a group of survivors of BT and ALL.